Impact of Neutrophil Extracellular Traps (NETs) on the Pancreatic Tumor Microenvironment

Pancreatic adenocarcinoma is a devastating malignancy characterized by a uniquely fibrotic pancreatic
tumor stroma that limits immune cell infiltration, promotes tumor growth through cancer-stromal signaling
pathways and limits delivery of systemic treatments. Development of novel therapeutic strategies that target
the pathophysiology of pancreatic cancer and the characteristic fibrosis associated with it are desperately
needed. Recently, the process of neutrophil extracellular traps (NETs), in which activated neutrophils release
their intracellular contents including DNA, histones, and granules into the extracellular tissue or circulation,
have been implicated in pancreatic cancer. Protein arginine deiminase 4 (PAD4) is an enzyme that
citrullinates histones to allow for unwinding and expulsion from the cell and is required for NET formation,
providing a potential therapeutic target for NET inhibition in cancer. PAD4-/- mice have diminished local and
systemic NET formation, resulting in limited tumor growth and improved survival in murine pancreatic cancer.
In addition to promoting pancreatic tumor growth, NETs also contribute to the spread of metastatic disease
and cancer-associated hypercoagulability. We have demonstrated that neutrophil DNA released from NETs
also activate pancreatic stellate cells (PSCs), the principle cell responsible for fibrosis in the pancreatic tumor
microenvironment (TME). Our overall objective in the current proposal is to identify the impact of NETs on
hypoxia, acidosis and metabolism in the pancreatic TME, and target NETs with pharmacologic inhibitors. In
Aim 1, we will utilize innovative electron paramagnetic resonance (EPR) to provide in vivo assessment of
oxygen content and pH in the pancreatic TME. We will compare tumors from wild type and PAD4-/- mice, as
well as mice treated with NET inhibitors to determine the influence of NETs on these parameters. NETs
release damage associated pattern molecules (DAMPs), which are known to influence metabolic processes
such as mitochondrial function and autophagy. In Aim 2, we will utilize the Seahorse assay to determine
how NETs alter cell metabolism in primary pancreatic cancer cells, pancreatic stellate cells and whole tumors.
We will also explore how NETs activate PSCs and increase fibrosis in the TME. These studies are critically
important to improving our understanding of the pancreatic tumor microenvironment. This work will provide
preliminary data in support of future grants funding mechanistic studies and target these processes at a time
when novel therapies are desperately needed for this devastating disease.

Public health relevance
Pancreatic cancer is a devastating disease with a 5-year survival of only 10%, characterized by early metastatic spread, and treatment resistance. New treatments that target the pathophysiology of this disease are desperately needed.